Role of cell-specific durotaxis in pulmonary arterial hypertension pathogenesis

Project Summary
Arterial remodeling is a crucial pathological change in diseases like pulmonary arterial hypertension (PAH), which
reduces the flexibility of arteries. Without treatment, PAH patients face a grim prognosis, with most dying within
a year of diagnosis and only a 45% survival rate at three years. Current drugs only slow the decline in pulmonary
function and do not stop or reverse the disease. It is essential to understand the biological processes behind the
pathophysiology of PAH for new targeted therapeutics. We propose that pulmonary arterial cells, especially
smooth muscle cells (SMCs), may migrate in response to changes in the stiffness of their extracellular matrix, a
process called durotaxis, which occurs independently of chemical or substrate-bound signals. In vitro tests
showed that PAH patient-derived pulmonary arterial endothelial cells, SMCs, and fibroblasts can migrate against
a spatial hydrogel gradient (stiffness 1-10 kPa), with PAH-SMCs being the most migratory. Additionally, Bio-
AFM-based nanoindentation of lung samples from a SUGEN/hypoxia PAH rat model revealed an extracellular
matrix gradient in the pulmonary arterial bed. Our proposal aims to track the spatiotemporal ECM stiffening in
the progression of PAH in mice and rat pulmonary arteries using Bio-AFM and to quantify matrix component
accumulation and crosslinking through immunostaining and orientation analysis. We found that introducing the
L994E FAK mutation in pulmonary arterial cells inhibited durotaxis in cell-based assays, confirming the need for
FAK-Paxillin interaction for stiffness sensing. We have developed a novel CRISPR FAKL994E knock-in (FAKL994E
KI) mouse model and a novel pulmonary arterial hypertension-on-a-chip (PulA-Chip) model to study the role of
the FAK/Paxillin complex in mechanosensing and muscularization. Both models are ready for use. We will also
investigate how actin-microtubule communication in PAH-SMCs affects ECM stiffness-directed durotaxis. Cell
adhesions assess matrix stiffness by exerting traction forces on the ECM through integrins, mainly αvβ3. We will
study the role of α-TAT1 in regulating the recycling of αvβ3/FAK/Paxillin complexes via clathrin-coated vesicles.
Understanding these mechanisms will help us to develop therapies in the future to stop or even reverse arterial
muscularization among PAH patients.

Public health relevance
Project Narrative Pulmonary arterial hypertension (PAH) is a rare but fatal disorder of lung characterized by extensive pulmonary arterial remodeling. This study aims to understand the role of the stiffness gradient of the extracellular matrix in the migration of pulmonary arterial cells, particularly smooth muscle cells, in PAH. By using novel transgenic mice (CRISPR KI FAK L994E) and novel microfluidic chip models, the research aims to investigate how changes in matrix stiffness drive cell migration and the involvement of specific proteins, such as FAK or Paxillin or microtubules, associated with creating molecular clutch that initiates cellular durotaxis in PAH.